Technology-Enhanced Asthma Care in Children at Clinic and Home (TEACCCH) Study

PROJECT SUMMARY/ABSTRACT
Candidate: Kristin Kan, MD MPH MSc is a pediatric physician and clinical investigator focused on designing
and implementing evidence-based, health-system interventions to support children with asthma. Dr. Kan’s
long-term goal is to be an independent physician-investigator and leading expert in implementation science
and health system interventions that improve the outcomes and quality of care for children with asthma.
Research Context: Of the 5.5 million US children with pediatric asthma, over half have uncontrolled
symptoms due in part to poor asthma self-management, leading to high rates of acute unscheduled care and
activity limitations. Supporting guideline-based preventive asthma care, especially adherence to medications,
is a critical step in reducing uncontrolled symptoms among high-risk asthma populations. There is evidence
suggesting that mobile health (mHealth) technologies can be part of an effective intervention to improve
adherence and symptom control. However, data from our previous mHealth asthma trial and other studies
suggest that limitations in mHealth use in real-world health care are partly attributable to the lack of optimizing
health system integration of the mHealth tool and the implementation strategy.
Specific Aims: (1) Optimize a mHealth pediatric asthma intervention and implementation plan with caregivers
and health system stakeholders through user-centered design workshops and interviews. (2) Conduct a
feasibility study of an adaptive, mHealth asthma intervention and multi-stakeholder implementation plan to
improve asthma symptom control and medication adherence.
Research Plan: To accomplish these aims, Dr. Kan will engage caregivers of children with asthma, clinical
staff, and health system administrators to refine the design of an existing mHealth asthma intervention, identify
health care services to integrate the intervention in health care delivery, and design an implementation
strategy. Dr. Kan will then conduct a feasibility trial with caregiver-child dyads, whom will be randomized to an
adaptive mHealth asthma intervention. Findings will help prepare for a future, full-scale hybrid implementation-
effectiveness trial.
Career Development Plan: Dr. Kan’s training goals include: (1) acquire experience in user-centered design
(UCD) methods, (2) develop expertise in clinical trial design & evaluation in health care settings, (3) increase
competencies in implementation science research methods, and (4) learn statistical techniques for analyzing
longitudinal data. Dr. Kan’s career development goals will be well-supported by an interdisciplinary mentorship
team, a planned series of didactic learning, and implementation of her research plan.
Environment: Dr. Kan has a NIH-funded core mentorship and advisory team, who are dedicated to
mentoring her to independence, and is also supported by Northwestern University and Lurie Children’s
Hospital, both with outstanding research infrastructures and commitments to supporting junior investigators.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to population health because pediatric asthma is a common chronic condition that affects millions of U.S children, especially children from urban, low-income communities. Children with persistent and poorly-controlled asthma should be taking a daily preventive medication, like inhaled corticosteroids, to reduce their risk for breathing problems leading to frequent emergency department visits and hospitalizations; however, a wide gap exists between what is recommended and adherence to medications. This project investigates using user-centered design methods and implementation science research to enhance a digital outpatient asthma intervention to improve asthma symptoms and adherence to medications.